Assessment of germline variants associated with immune-related adverse events following immune checkpoint inhibitors

PROJECT SUMMARY
Immune checkpoint inhibitors (ICIs) have revolutionized cancer treatment but come with the significant downside
of immune-related adverse events (irAEs), which can lead to treatment discontinuation, hospitalization, or even
death. Understanding the mechanisms behind irAEs is imperative, not only to minimize toxicity but also because
irAEs are paradoxically linked to positive anti-tumor responses, while their aggressive management correlates
with increased relapse risk.
Our research posits that gaining a nuanced understanding of the biological mechanisms underlying irAEs could
enable clinicians to differentiate between clinical benefits and harmful side effects, thus optimizing
immunotherapy efficacy. We have previously shown that germline variants are associated with irAEs, and have
also noted that somatic alterations impact immunotherapy efficacy by interacting with the immune environment.
Short-term Objectives:
Aim 1: We plan to conduct the largest genome-wide association study (GWAS) for irAEs, covering over 13,000
ICI patients, using novel imputation and survival models. This will include aggregating pan-cancer data across
multiple cohorts. We aim to characterize shared and distinct genetic architectures of irAE subtypes and evaluate
how germline variants interact with therapy agents to influence safety and efficacy outcomes. We will aggregate
germline data for 13,000 patients to conduct a GWAS for irAEs and clinically annotate and aggregate pan-cancer
data. Sub-population GWAS will identify subtype/organ-specific germline associations. Longitudinal competing
event models will be used to assess the mechanistic effects of each variant on safety and efficacy outcomes.
Aim 2: We will delve into the cell-type-specific mechanisms, tumor microenvironment interactions, and ancestral
variability of germline irAE variants. Bulk and single-cell RNA-seq (sc-RNA-seq) data will be integrated to
elucidate these mechanisms, and somatic alteration interactions will also be analyzed. RNA-seq and tumor/blood
scRNA-seq will be utilized to identify cell-type-specific mechanisms and interactions of germline variants with
somatic drivers.
Long-term Objectives: Our long-term goal is to personalize immunotherapy by tailoring it to individual genetic
makeup, thus minimizing irAEs and optimizing efficacy. This could dramatically improve cancer treatment
outcomes and reduce healthcare burdens associated with complications, contributing to public health. By
dissecting the genetic landscape and its interaction with immunological and somatic factors, our work aims to
pave the way for safer and more effective cancer immunotherapies.

Public health relevance
PROJECT NARRATIVE This research seeks to enhance public health by pinpointing genetic markers that can forecast who is at risk for serious side effects from widely-used cancer immunotherapies, thereby enabling personalized treatment plans. By investigating how these genetic factors interact with immunological and somatic variables, we aim to improve the safety profile of these therapies, reducing healthcare burdens associated with treatment complications. The project has the potential to minimize treatment-related complications on a broad scale, thereby enhancing the overall quality of healthcare and contributing to a reduction in illness and disability across the population.